Drivers of genetic heterogeneity and their impact on polygenic risk prediction

Abstract Genome-wide association studies (GWAS) have informed us about the genetic architecture of complex traits and diseases by identifying common genetic risk variants. Typically many genetic variants conferring small increases in risk underlie disease variation in a population. Summarizing the effects of these genetic risk variants can measure an individual’s genetic predisposition, which is done by calculating a polygenic risk score (PRS). PRS show clinical promise in identifying individuals at the extremes of the genetic risk distribution. However, the potential benefits of using PRS in risk stratification may be curtailed due to loss of predictive power of PRS in groups of non-European ancestry. PRS are commonly calculated from GWAS conducted in European populations because of large sample sizes. PRS derived from European GWAS suffer the greatest loss in predictive power in African populations. Currently we do not know the reasons for this loss of predictive power. Investigating the factors limiting the transferability of PRS will inform future avenues of research into developing more generalizable PRS. Since few GWAS have been conducted in African ancestry individuals, the proposal will perform a GWAS in Sub-Saharan African populations for height in Aim 1 to contribute to our knowledge of the genetic architecture of a complex trait in diverse African populations. Through the GWAS in Aim 1, genetic variation not present in non-African populations that affects height can be uncovered. In Aim 2, the proposal will investigate the role of differences in linkage disequilibrium (LD) structure across populations in limiting the transferability of PRS. GWAS rely on LD between a genotyped marker and the causal variant, so the variants included in a PRS are not necessarily causal. To test whether differences in the tagging of shared causal variants between populations limit the transferability of PRS, this proposal will identify instances of differential tagging of causal variants between Europeans and Africans and cases where multiple associations at a locus are obscured by high LD in Europeans, which can be interrogated with low LD in Africans. In Aim 3, this proposal will study the mechanisms driving differences in effect size of variants shared across ancestries, specifically the role of gene by gene (GxG) and gene by environment (GxE) interactions. Variants with the most disparate effect sizes between Europeans and Africans will be examined for evidence of interaction effects. GxG interactions for a candidate variant will be tested based on its local genomic ancestry. GxE interactions will be tested using two groups of similar ancestry but differing by status of living in a rural or urban environment. In all, these analyses will inform our understanding of the roles of LD structure and GxG and GxE interactions in limiting the transferability of PRS across populations.

Public health relevance
Project Narrative The lack of sampling of diverse ancestries in human genetics poses a problem of equity in genomic medicine, wherein genetic models for disease risk prediction have limited utility in groups of non-European ancestry compared to groups of European ancestry. Understanding the factors limiting the generalizability of genetic risk prediction can help inform the field in how to decrease the disparities in prediction accuracy between European and non-European groups. The proposed research here leverages a large cohort of Sub-Saharan African genomes and data from other studies to investigate the roles of differences in linkage disequilibrium patterns and gene-by-gene and gene-by-environment effects in this issue.